RANDOMIZED TRIAL ON IV IMMUNOGLOBIN TO PREVENT NEONATAL INFECTION

The hypothesis to be tested is that the use of IVIG will reduce the incidence of nosocomial neonatal injection in infants weighing between 501 and 1,000 gms.